Neuropathogenesis of Retroviral Infections

The overarching hypothesis is that the brain is an important reservoir for retroviruses because retroviruses are able to infect long lived terminally differentiated cells and viral products released from these cells can cause immune activation and neuronal injury.
Aim 1: To understand the mechanism of viral persistence in brain:
While my lab has been studying the mechanism of viral persistence in the brain in the context of HIV
infection for several years, we are now studying the same phenomenon in the context of endogenous retroviruses and chronic dengue viral infection in the brain. Lessons learnt from HIV are widely applicable to other viral infections. Recent studies suggest that these viruses may play an important role in the pathophysiology of several neurodegenerative diseases. Hence the study of viral persistence and transmission within the brain is an excellent opportunity to shed new light on the pathophysiology of these diseases and to identify new therapeutic targets. The brain is a unique site of viral latency since the cells have a very low turn over rate and hence viral sequences can reside there for the life of the individual. For example, we have found that HIV can be transmitted from cell to cell without complete viral production. We are now developing in vitro and in vivo models to study this phenomenon and determine if other retroviruses and those that cause chronic encephalitis can also similarly persist in the brain and transmit from cell to cell and thus escape the immune system.
Aim 2: To investigate the mechanism of neuronal injury by HIV and endogenous retroviruses.
Despite the use of antiretroviral agents and excellent control of the virus in the periphery, HIV infected patients continue to develop cognitive impairment. Currently available antiretroviral agents have no effect on the production of early viral proteins once the virus has integrated into the chromosome. One of these proteins, Tat, has been shown to be neurotoxic. Our laboratory was one of the first to demonstrate its toxic potential and has extensively investigated the mechanism by which it causes neurotoxicity. We have shown that Tat can complex with amyloid beta peptide to form highly neurotoxic protein aggregates. We have developed an assay to quantify Tat in spinal fluid.
We have also discovered that Tat protein of HIV is present in the CSF of 1/3 of HIV infected patients despite undetectable virus while on antiretroviral therapy. We are developing therapeutics that includes antisense molecules and small molecules to block the effect of Tat on HIV replication and neurotoxicity.
We have recently shown that the envelope protein of an endogenous retrovirus (HERV-K) can be detected in the spinal fluid of patients with ALS and can also cause neurotoxicity that can be blocked by an antibody to the protein. We have mapped the subcellular pathways involved in the neurotoxicity.
We are studying the mechanism underlying the neurotoxicity and have screened a panel of anti-retroviral drugs against HERV-K. Based on these findings a clinical trial is being conducted for treatment of patients with ALS.
Aim 3: To develop therapeutic approaches to prevent viral activation and formation of viral reservoirs in the brain.
We have generated cell lines with inducible expression of HIV-Tat protein and the HERV-K virus.
These cell lines are being used in high-throughput screening assays to screen for small
pharmacological compounds that suppress their production. We have identified several potential
candidates for further characterization. We have also developed antisense molecules to Tat that are
being further characterized for their therapeutic potential.
In summary, we have shown that astrocytes in the brain are an important reservoir for HIV and that
cell to cell contact with lymphocytes is necessary for viral entry and the lysosomal pathway in these cells regulates the intracellular trafficking of the virus and its ultimate ability to successfully infect these cells. Further, we have shown that the HIV protein Tat and the env protein of endogenous retrovirus-K are neurotoxic and we are now studying the underlying mechanisms involved in these effects. We are now developing therapeutic strategies for preventing the activation of these genes.
Aim 4: Study of undiagnosed neuroinflammatory diseases. Many patients with neuroinflammatory
diseases go undiagnosed for years without proper treatment. We have developed a protocol to study these patients to determine the underlying pathophysiology and initiate appropriate therapy. We have
recently identified some new neuroimmune disorders triggered by an infection.

Aim 5: To investigate the neuropathogenesis of COVID-19 and develop antiviral therapies:
We have initiated the characterization of the neuropathological findings in autopsy brain tissue by immunohistochemistry and postmortem MRI scanning. The focus is to characterize the neuronal damage and immune activation in the brain and determine if there is any evidence of persistent viral infection of the tissues. We have also developed antisense oligonucleotides targeted against the SARS-CoV-2 genome which will be tested for efficacy in an infection assay for further therapeutic development. We have developed two clinical protocols to study patients with neurological complications of COVID and those who develop a post-viral syndrome similar to myalgic encephalomyelitis/chronic fatigue syndrome. We are in the process of developing another treatment protocol for these patients where we will use immunomodulatory drugs in a placebo controlled study.